Health 360x Clinical Research Platform for Scalable Access to Clinical Trials

Lack of participation of African-Americans, Latinx communities and rural populations
leads to persistent health disparities. The National Academy of Medicine, and research
organizations have sounded the alarm about the impact on the clinical trial enterprise,
and the health of Americans in general. The national Academy recommends strategies
that will increase access to clinical research at the point of care. The COVID-19 public
health pandemic has revealed significant health disparities affecting America’s black and
brown communities, with 2.4 to 7 times mortality rates compared to white Americans.
Current vaccine trials have enrolled less than 10% Blacks. This experience mirrors
numerous NIH studies across institutes and centers, as well as industry studies.
The goal of this SBIR Fast-Track proposal is to develop the knowledge, products and
processes needed to implement Health 360x Platform Service in real world practices
serving predominant African Americans, Latinx, and patients from rural communities.
We will implement the following aims:
1)Specific Aim 1-Phase I. Design Health 360x Clinical Research Platform (Health 360x)
2) Specific Aim 2-Phase II. Test the feasibility of implementing Health 360x SOP in the
workflow of three practices, serving under-represented patients.
3)Specific Aim 3-Phase II. Evaluate the adoption, implementation, effectiveness, and
maintenance of Health 360x in practices serving under-represented patients
Primary outcome: Adoption and implementation progress of Health 360x with
performance indicators based on the CVIS Registry protocol; IRB/informed consent;
PhenX surveys for social determinants; Recruitment and Retention rates; Cost analysis.
This Fast-Track SBIR project will directly address NCATS priority on research efficiency
by implementing a commercially viable clinical research platform that adapts to
community practice settings, and is scalable, to recruit, track and retain patients who are
under represented in biomedical research.

Public health relevance
Project Narrative This project addresses the under representation of African Americans, Latinx and rural populations in clinical research by implementing and evaluating processes for the point of care adoption of Health 360xClinical Research Platform